Understanding Pain of Gastrointestinal Origin in Women that Serve in OEF/OIF

? DESCRIPTION (provided by applicant): The objective of our study is to elucidate the mechanisms underlying the sexually dimorphic effects of early life stress (ELS) on pain perception in female veterans. Our overarching hypothesis is that exposure to adversity in early life predisposes female veterans to heightened visceral pain via a central mechanism involving abnormalities in brain-gut communication. RESEARCH PLAN: Under Specific Aim 1, we will test the hypothesis that stress in early life serves as a risk factor for heightened pain in adulthood produced by chronic stress. Having identified in preliminary experiments increases in stress-responsive genes within the central nucleus of the amygdala (CeA) of female rats exposed to ELS, in Specific Aim 2 we will test the hypothesis that heightened pain perception in adulthood following ELS is mediated by central increases in stress-responsive genes. Specific Aim 3 will explore the hypothesis that centrally driven epigenetic changes make an individual more susceptible to chronic stress and contribute to the sexually dimorphic effects of ELS on pain perception in adult female rats. METHODOLOGY: We will employ validated rats models that recapitulate visceral pain in patients. Specifically, we will measure colonic sensitivity by quantifying the number of abdominal cramps in response to colonic distension. Stress in early life will be induced by odor shock conditioning in neonatal rat pups. Stress in adulthood will result from repeated exposure for 1 hour each day to a water avoidance stressor (WAS). We will investigate whether ELS serves as a predisposing risk factor for heightened visceral pain in response to chronic WAS in adulthood. We also will investigate whether knockdown of amygdaloid gene expression using specific antisense oligodeoxynucleotides (ODNs) inhibits the development of pain following ELS. Finally we will use an array of epigenetic approaches targeting histone acetyltransferases within the CeA to gain further mechanistic insight into stress-induced visceral pain. ANTICIPATED RESULTS: For Specific Aim 1 we expect to show that rats experiencing adult stress will have visceral hypersensitivity compared to controls. However, we anticipate that that there will be a greater visceral sensitivity to the adult stress following ELS. We also expect an exaggerated activation of the HPA axis indicated by an elevated systemic CORT and ACTH, as well as increased fecal pellet output (FPO) in response to WAS in all experimental groups, however the magnitude of the change will be greater in response to ELS. For Specific Aim 2, we anticipate that imbalances of stress responsive genes contribute to abnormal visceral pain perception in adulthood following ELS. In experiments proposed under specific aim 3 we expect to show that heightened visceral pain following ELS may be modulated through epigenetically mediated mechanisms within the CeA. RELEVANCE TO VETERANS HEALTH: The VA provides specialized health care for female veterans, however limited research has focused on illnesses experienced by female Veterans. Of importance to this proposal, female veterans with anxiety-related disorders have higher rates of childhood abuse. Our findings may identify novel approaches to improve the treatment of pain in female Veterans.

Public health relevance
PUBLIC HEALTH RELEVANCE It is our working hypothesis that a history of early life stress may increase the susceptibility ofa soldier, especially a female soldier, to the adverse effects of combat-related stress and the subsequent development of adult pathologies. Successful completion of the aims proposed within this application will offer new insights into the mechanisms of brain-gut dysfunction in relation to female physiology that likely lead to chronic abdominal pain. More importantly our findings may identify novel targets for new therapies directed at the brain to improve the treatment or even reduce the risk for the development of visceral pain in female veterans deployed in OEF/OIF. This proposal is highly relevant to the patient-care mission of the VA, since the VA cares for a Veteran population that has been exposed to severe stress during deployment, which, when combined with a history of early life stress, may lead to the development of chronic visceral pain.